Tulane National Primate Research Center AIDS SPF Breeding Colony Maintenance

Project Summary/Abstract - Overall
The Tulane National Primate Research Center (TNPRC) has one of the largest rhesus monkey breeding colonies
in the United States. The objective of this application is to request funds for continued support and maintenance
of the U42 supported SPF Indian-origin rhesus monkey breeding colony at the TNPRC. The specific aims
address the components specified in the funding opportunity announcement (FOA) and are divided into the
Overall program description, Husbandry and Management Core, Viral Testing Core, and MHC Genetic Typing
Core. Program income and TNPRC funds will be used to support components of the program not covered by
grant funds including: per diem for any colony animals in excess of the animals supported by this application,
additional testing required for those animals, infrastructure repairs and improvements, veterinary clinical and
pathology support, behavioral management support, and portions of the genetic testing.
Specific Aims:
Overall. To maintain the existing SPF colony and distribute available animals to the NIH funded HIV/AIDS
research community.
Husbandry and Management Core. To provide husbandry and veterinary care for the SPF breeding colony
established in the existing U42 grant. This includes a robust program for clinical veterinary medical care and
behavioral management. The colony has reached a mature self-sustaining status with ideal demographics to
produce up to 105-150 animals available for assignment each year based on production and demand. Program
income generated by the animal sales will be returned to an account for use in supporting the aims of the grant.
Viral Testing Core. To assure the SPF status of the colony through continued viral testing of existing breeding
colony animals and all offspring. Continue to expand characterization of the colony beyond the required 4 viruses
to include agents such as measles virus, SARS-CoV-2, Trypanosoma cruzi, and other emerging infectious
diseases that threaten nonhuman primates.
MHC Genetic Typing Core. To continue genetic analysis and MHC typing of the colony and provide expanded
genetic characterization through enhanced techniques.

Public health relevance
Project Narrative - Overall Tulane National Primate Research Center (TNPRC) has one of the largest specific pathogen free (SPF) rhesus monkey breeding colonies in the US, a resource that has provided animals for NIH funded research projects for several decades. Over half of all research projects at TNPRC are initiated by outside investigators, making this resource essential to the success of many NIH-funded researchers across the country. Experienced leadership and significant infrastructure investment, combined with proven techniques in breeding colony management, ensure continued responsible stewardship of this nationally recognized resource.